Large scale gene expression analysis of cellular states

DESCRIPTION (provided by applicant): In this project we aim to create a first installment of data generation and analysis for the LINCS program. Specifically, we will use a novel approach to genome-wide expression profiling developed at the Broad Institute (based on a Luminex bead assay) to catalog the cellular consequences of diverse small-molecule and genetic perturbations in a breadth of human cell lines. We will perform these perturbations in 20 cell types chosen for their biological diversity and interest to the broad scientific community. For the genetic perturbations, we will profile the cellular consequences of treatment of each of these cell lines with 4,000 small-molecule compounds of interest to the community (including compounds emerging from the MLPCN network). For the genetic perturbations, we will perform both gain- and loss-of-function studies for 3,000 human genes. The resulting expression data will be made publicly available without restriction, and importantly, will be accompanied by a series of analytical tools that will enable researchers to query the data via a web interface. The project has been configured so that it a) can scale to larger efforts in the future, b) can accommodate technology platform changes in the future, and c) can accommodate the integration with other types of data.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project is expected to enable the biomedical research community to interact with a rich database of functional perturbational data that can support a) the discovery of function of unknown components of the genome, b) the annotation of function of small molecules, and c) the linking of disease sates with small-molecule or genetic perturbational signatures, thereby providing insight into the biological basis of disease and perhaps even initial insights into new therapeutic opportunities.